EPR STUDY OF GTP FORM OF P21 RAS W/ SELECTIVE 17O LABELING OF THREONINE

As a molecular switch the ras protein undergoes structural changes that couple recognition sites on the surface of the protein to the guanine nucleotide-divalent metal ion binding site. X-ray crystallographic studies of p21 suggest coordination between threonine-35 and the divalent metal ion plays an important role in these conformational changes. Recent ESEEM studies of p21 in solution, however, place threonine-35 further away from the metal and were interpreted as weak or indirect coordination of this residue. We report high frequency (139.5 GHz) pulsed EPR spectroscopy of p21[unreadable]Mn(II) complexes of GMPPNP that probe the link between threonine-35 and the divalent metal ion. In particular, we determine the 17O hyperfine coupling constant of [17Og]Thr 35 is determined to be ~1.1 G in the GTP form. This value is much smaller than reported values (1.6 - 4 G) for 17O-enriched aquo-and phosphato-ligands in other complexes of Mn(II). These results are in agreement with direct, weak coordination of this residue as suggested by Halkides et al. (1994) Biochemistry 33, 4019.